Change in social adaptive action and brain connectivity in infants' first 6 months

? DESCRIPTION (provided by applicant): The current project will identify maturational changes in the infant brain that accompany important transitions in social behavior in the first 6 months o life. This work is motivated by a surprising feature of a recent study in which we identified the earliest known indicators of social disability in autism (Jones & Klin, Nature, 2013). The data falsified a prior hypothesis by revealing that eye-looking-a basic mechanism of social adaptive action in typical infants-was not immediately diminished in infants with autism; instead, infants with autism exhibited a slight but significant increase in eye-looking at 2 months, which then declined; in contrast, typical infants exhibited a relative low point in eye-looking at 2 months, which then increased. The timing of this difference highlights a narrow developmental window, around month-2, that spans an important period of dynamic transition in typical infants. At approximately 4-6 weeks, reflex-like neonatal predispositions-including among others: non-social, endogenous smiling1, 2; reflexive imitation3-5; and reflexive attention to faces6-decline. This decline is followed by major changes in infant behavior: after month 2, infants begin to engage in contingent social interaction: they increase time spent looking at others' eyes10,11 and produce socially-elicited smiles during interaction with caregivers2,12,13. The neural mechanisms supporting these critical transitions are thought to be a shift from subcortical to cortical control1,6,8,14-16, with initial reflex- like predispositions (subserved by subcortical structures) declining as cortical control matures. This account appears well-fitted by our eye-tracking data11, and suggests a very specific hypothesis in autism: in infants with autism, reflex-like (subcortically-mediated) orientation to the eyes of others may initially be intact, while the emergence of experience-dependent (cortically-mediated) voluntary eye-looking subsequently fails. Despite the appeal of this proposed model, no studies have prospectively tracked the development of these neural systems and their relationship to unfolding behavior in typical development, a critical step before examining disruptions thereof in autism. In N=50 typical infants we will examine developmental changes in brain connectivity associated with 2 critical transitional behaviors, eye-looking and social-smiling, to identify: (1) brain networks differentialy associated with either decline in reflexive eye-looking or with the emergence of voluntary eye-looking, (2) brain networks differentially associated with either the decline of endogenous, reflexive smiling or with the emergence of socially-elicited smiling, and (3) brain networks common to social adaptive action. Behavioral and neuroimaging measures will be collected longitudinally at 7 and 3 time points, respectively, between birth and 6 months. Brain connectivity will be measured both structurally (as tract- specific diffusion parameters, including fractional anisotropy (FA) and mean diffusivity (MD), via diffusion tensor imaging (DTI) and tractography) and functionally (via measures of resting-state functional connectivity).

Public health relevance
PUBLIC HEALTH RELEVANCE: The proposed project will prospectively track maturational changes in the infant brain that accompany pivotal transitions in two social behaviors, looking at the eyes of others and social smiling, in typical infants between birth and 6 months. This project will fill a critical gap in knowledge of brain mechanisms underlying social adaptive action in typical development, thereby enabling future insights into the disruption thereof in autism.